Using neuroeconomics to disentangle the transcriptional mechanisms underlying resilience versus susceptibility to stress

Abstract
Depression and other stress-related psychiatric disorders are characterized by dysfunction in mood and
motivation. Understanding the molecular mechanisms mediating dysfunction in these processes and the factors
underlying stress-susceptibility vs. stress-resilience is the primary goal of the parent R01 grant in the lab of Eric
Nestler. The parent R01 grant takes an unbiased large-scale bioinformatics approach to characterize the
transcriptional regulators of stress action and their impact on affective processes. While the parent R01 grant
uses standard behavioral neuroscience approaches to measure motivation and reward-related endpoints in
rodents, these measures are often simple in nature and limited in their ability to approximate the complexity of
affective processes observed in human patients struggling with stress-related disorders. Thus, the goal of this
supplement proposal is to expand the animal paradigms employed by the parent R01 grant with a focus on
enhancing the translational validity of the behavioral measures used for the study of depression. This will be
accomplished by leveraging the skills of physician-scientist and psychiatry resident Brian Sweis, who has
expertise in complex animal behavior and has recently developed a novel set of tasks translated for use across
species that applies principals of neuroeconomics in order to capture evolutionarily conserved interactions
between cognition and affect. This proposal aims to generate a rich behavioral data set to match that of the “big
data” available in the parent R01 grant’s genome-wide sequencing studies. This supplement will enhance the
novelty and utility of the parent project while remaining within the scope of the parent project and will provide
novel skills in molecular neuroscience and bioinformatics to the trainee.

Public health relevance
Project Narrative This project aims to enhance the complexity and translatability of behavioral readouts available for mouse models of depression in order to better understand the role of transcriptional regulators underlying stress- susceptibility vs. stress-resilience – one of the key goals of the parent R01 grant. This proposal will provide novel training to the physician-scientist Brian Sweis in molecular neuroscience and, more specifically, large-scale genome-wide bioinformatics synergistic with his expertise in cross-species neuroeconomics, concurrent with his residency training in psychiatry.